SoS:B10:ldentifying and Encouraging Connections among Data Reuse, Scientific Innovation, and Scientific Careers

PROJECT SUMMARY {See instructions):
This project has two main goals: measuring the impact of research data reuse on diversity and novelty,
and identifying synergistic data-method-researcher combinations to spur scientific discovery.
Access to scientific data is critical for advancing research quality and efficiency. Yet, bibliometric studies
have uncovered biases in publication impact and citation patterns, raising concerns that such disparities
might affect how researchers reuse data. Developing robust metrics to identify and rectify these
imbalances is the focus of this work.
The project will construct networks and graph databases that connect research objects such as
publications, analysis code, datasets, and variables. These networks will provide insight into datasets'
influence on research diversity, author interactions, and code reuse for scientific advancements. Focusing
on biomedical research allows for a varied examination of the types of data, outputs, and potential
high-impact findings, like new therapeutics or research methods.
Initially, the project will create knowledge graphs from ICPSR and PhysioNet datasets, supplemented with
author and code metadata from databases like Dimensions and OpenAlex. Subsequent phases will
assess the impact of data through diversity and novelty metrics, refined in consultation with stakeholders.
Finally, the project will recommend strategic partnerships to promote equitable data use and
groundbreaking reuse applications.

Public health relevance
RELEVANCE {See instructions): This research aims to make better use of existing health-related data by identifying new ways to analyze it, potentially leading to groundbreaking discoveries like novel medical treatments. By measuring how data is reused and fostering collaborations, the project serves public health by accelerating scientific breakthroughs and improving our ability to fight diseases.